Administrative Core and Management Plan

The Administrative Core (AC) will provide overall oversight, coordination, and logistics support for the operation of the proposed National Transdisciplinary Collaborative Center for African American Men's Health (NTCC).